Administrative Core

PROJECT SUMMARY/ABSTRACT
The transfer of information between macromolecules is one of the defining aspects of life at the molecular level
and is critical for all homeostatic and disease processes. The Nebraska Center for Integrated Biomolecular
Communication (CIBC) fosters interdisciplinary research focused on spatial and temporal aspects of
biomolecular communication using approaches that span a continuum ranging from the molecular to the tissue
levels. CIBC has significantly increased biomedical research expertise in Nebraska by developing independently
funded interdisciplinary research collaborations that are pursuing high impact research into complex diseases
from diverse perspectives. The goal of the Administrative Core in Phase 2 is to continue to provide the overall
coordination and administrative infrastructure that will enable CIBC to continue growing the interdisciplinary
biomedical expertise and approaches needed to understand the regulation of biomedically relevant
communication pathways. The specific aims are: 1) provide the scientific, administrative, and programmatic
leadership and research infrastructure needed to ensure CIBC operations function effectively and efficiently and
support progress toward the Center’s overall goals and specific aims, 2) coordinate a strong mentoring and
development plan to catalyze the research and career development of early stage investigators and their
transition to independent investigator status, 3) support and expand a suite of Center-wide enrichment activities
to create a collaborative research environment, provide meaningful opportunities for CIBC members to interact
with one another, and promote a clear pathway by which additional faculty, postdoctoral research associates,
and graduate and undergraduate students will affiliate with the Center; and 4) support CIBC’s eventual transition
to a self-sustaining center of biomedical research excellence by supporting Center members in securing program
project grants; large-scale, multi-investigator grants; individual investigator projects; and training grants. By
accomplishing these aims, the Administrative Core will support CIBC’s central goals of 1) supporting the growth
of biomedical research infrastructure at the University of Nebraska and 2) advancing the understanding of the
regulation of biomedically relevant communication pathways and the development of interventions to detect,
prevent, and treat disease, improving health outcomes among the broader population.